Critical Care Informatics

Abstract
This is a renewal application for the Critical Care Informatics grant (NIBIB R01 EB017205) that was awarded to
the Laboratory for Computational Physiology (LCP) in 2014. This grant has supported the development of the
Medical Information Mart for Intensive Care (MIMIC) research database, which is a de-identified database for
research and health data science education around the world. We aim to address the foremost issues in machine
learning in healthcare today, focusing on health disparities, algorithmic bias, and understanding the barriers to
effective and equitable implementation of algorithmic models. Our proposal will enrich MIMIC with new data
types and sources, including publicly available population health datasets, advance progress on a federated
critical care dataset, and add a new module with COVID-19 specific ontology and codes. Our research will build
on prior findings showing the pervasiveness of hidden socio-demographic bias in data sources including clinical
data, medical images, and narrative patient documentation. Health care data science ultimately exists for the
purpose of improving human health. Yet, extremely few models published in research papers have impacted
clinical care due to challenges in implementation. In layman’s terms, this means knowledge gained about tests
and treatments leads to the best possible outcome for every patient in the intensive care unit (ICU) regardless
of demographic. We will conduct a rigorous qualitative research study to better understand the barriers faced by
key stakeholders - clinicians and data scientists - in the development and implementation of equity-centered
artificial intelligence. This information will be used to develop guidelines to integrate with implementation science
frameworks to support the effective implementation of equitable AI in clinical settings. With these aims, MIMIC
will significantly expand the relevance of this research resource to a greater diversity of investigators including
those in the social and behavioral sciences and public health and continue to be a resource for clinical research
and increasingly sophisticated model development, advancing our understanding of critical issues of fairness
and equity in healthcare, data science, and the broader society.

Public health relevance
Project Narrative The Medical Information Mart for Intensive Care (MIMIC) is the first publicly available electronic health record database that is used by thousands of researchers around the world to study important questions and build clinical algorithms in the intensive care unit. In this renewal grant, we propose to enhance MIMIC new data types and sources, including publicly available population health datasets and develop new methods to identify biases in MIMIC and prevent them from being encoded in the algorithms. We will conduct a rigorous qualitative research study to better understand the barriers faced by key stakeholders - clinicians and data scientists - in the development and implementation of equity-centered artificial intelligence.